Advancing Multi-Color EM via Direct Detector-enabled 4D-STEM

PROJECT SUMMARY / ABSTRACT
This competitive supplement application requests funds to procure a high speed direct electron counting detector
for analytical Energy Filtered TEM (EFTEM). This detector will allow us to accelerate the validation and
performance benchmarking of new multi-label, elemental probes under development to scale the impact and
accessibility of multicolor electron microscopy (ColorEM). This work will be conducted in the context of an active
research project that is advancing the development of a novel method for ColorEM, employing new technologies
for ultra-high-speed 4D-STEM (5 R01GM138780-03). This funded project is performing the feasibility studies
and surmounting the technical challenges to: 1) make multi-labelled EM specimens with elemental probe
combinations optimized for ColorSTEM (and extensible to all methods for ColorEM); 2) troubleshoot the first use
of potentially transformative new technologies for STEM detection and associated capabilities for atomic-number
(Z) contrast imaging; and, 3) work out the methodology for processing/analysis of very large primary data sets
so as to accelerate elemental differentiation/signal interpretation and allow for display of ColorSTEM results. The
ultra-fast direct electron detector requested, will allow us to accelerate and sharpen our ability to record,
compare, and optimize the performance elemental probe combinations (for both signal-to-noise and differential
contrast) as well as provide for a more sensitive and accurate validation of the quantitative performance of our
data processing routines, which work hand-in-hand with the labeling chemistry to allow us to reliably and
accurately discern the signal recorded from one selectively labeled structure from the specific signal of another.
The equipment item requested is an Apollo (Direct Electron, LP), low-noise, high-speed electron-counting, direct
detection device (DDD) for transmission electron microscopy, which possesses an industry-leading signal-to-
noise and throughput specification that will allow us to more rapidly and accurately validate the performance of
new elemental probes, thus accelerating the completion of Aims 1 and 3 of the parent award.

Public health relevance
NARRATIVE This supplement requests funding for equipment, a new electron counting direct detector for energy filtered transmission EM, to accelerate the validation and performance benchmarking of new multi-label, elemental probes and associated analysis software for performing multicolor electron microscopy (ColorEM) employing new methods and technologies for 4D-STEM. The proposed outcome of this focused effort is to accelerate the delivery of a functional solution for 3 dimensional (3D) localization and differentiation of different molecular complexes in cells and tissues that surpasses the current state-of-the art in terms of resolution, throughput, and broad accessibility.